TRIM21 as a regulator of UVB- and cytosolic DNA-driven IFN responses in lupus

Patients with systemic lupus erythematosus (SLE) experience photosensitivity, with exposure to ultraviolet light
(UV) often driving lupus flares, triggering symptoms like joint pain and fatigue, in addition to causing cutaneous
lesions. However, although the mechanism(s) linking UVB exposure to systemic effects are unclear, type I IFNs
are known to play a role. Our previous work has shown that the E3 ligase TRIM21 is a negative regulator of IFN
expression. Interestingly we observed that Trim21-/- mice develop spontaneous skin lesions in response to DNA
detection in the skin. This prompted us to investigate whether Trim21-/- mice were hyperresponsive to UV in
driving skin inflammation. Trim21-/- mice develop more severe skin inflammation in response to UVB compared
to wild type, as well as splenomegaly and enhanced levels of systemic IFNs. Regarding targets for TRIM21 in
regulating UVB-induced responses we have identified DDX41, a relatively under studied DNA sensor as a
potential target. We hypothesize that TRIM21 acts as a gatekeeper against systemic disease by preventing
uncontrolled systemic IFN responses driven by cytosolic DNA sensing, such as demonstrated in the UVB skin
model and that this may have implications for photosensitivity in SLE. To evaluate this, we propose the following:
Aim 1: Assess the role of TRIM21 in UVB-induced skin inflammation and how it contributes to systemic
changes. We will define what immune cells are key to systemic disease in the Trim21-/- mice and how STING-
and IFN-dependent and independent pathways mediate the drive the transition from local to systemic
inflammation in response to UVB in the absence of TRIM21.
Aim 2: Determine the role of TRIM21 and DDX41 in regulating cGAS-STING signaling in response to UVB.
We will investigate how TRIM21 and DDX41 is regulated downstream of UVB and ask how their loss alters the
composition, stability and function of the STING signalsome using a combination of biochemistry and proteomics.
Aim 3: Define how loss of TRIM21 contributes both cutaneous and systemic UVB-driven IFN responses.
Analysis of PBMCs and skin biopsies from SLE patients will determine how TRIM21 may contribute to
photosensitivity in SLE and the role of STING in driving these responses.
Impact: This project will determine the mechanisms underlying this hitherto unknown role of TRIM21 in
controlling UVB-driven systemic IFN responses and ask whether altered TRIM21-regulated pathways can
explain the link between UVB exposure and increased risk of lupus flare in SLE.

Public health relevance
Ultraviolet (UV) light has long been known to be a trigger for driving flares or worsening systemic disease in systemic lupus erythematosus (Lupus) but what protects healthy individuals from mounting similar responses is unknown. This project will investigate TRIM21, a known regulator of inflammatory and anti-viral responses, and its role as a central gate keeper regulating cellular responses to DNA damage or UV exposure. It will translate these findings to enhance our understanding of the role of TRIM21 in human disease and ask how changes in TRIM21 activity or expression contributes to the dysregulated anti-viral responses observed in lupus.